Circadian-metabolic crosstalk in tanycyte endocrine signaling and neurogenesis

Project Summary/Abstract
Circadian clocks are ubiquitous in tissues, regulate many metabolic functions, and their misalignment or
disruption contributes to deleterious health consequences. Although molecular underpinning of the circadian
clock is well-studied, the role of the clock in tissue-specific metabolic functions, such as that of tanycytes, is
poorly understood. Tanycytes, specialized hypothalamic glial cells, gate the entrance of nutrients and hormones
to the brain, signal to hypothalamic neurons, and generate new neurons relevant for feeding and sleep.
Circadian rhythms in peripheral signaling to the brain are necessary to maintain whole-body energy homeostasis,
but the contribution of cell-autonomous circadian rhythms in tanycytes to this process is completely unexplored.
My recent work has identified the presence of these rhythms in tanycytes and found that the core circadian clock
gene Bmal1 in tanycytes regulates leptin signaling, diet-induced weight gain, and adult neurogenesis in female
mice. This proposal examines the mechanisms of circadian regulation of tanycyte endocrine signaling
and neurogenesis, their relevance to feeding behavior, and the contribution of diet and sex differences
to these processes. I hypothesize that there is an autonomous circadian rhythm in tanycyte leptin signaling to
the arcuate nucleus of the hypothalamus, the brain's feeding control center (Aim 1). Based on published and
preliminary data, I propose that tanycyte circadian rhythms influence feeding behavior through endocrine
signaling and neurogenesis (Aim 2). I further hypothesize that tanycyte neurogenesis is controlled by circadian
rhythms both at the level of initial cell division and differentiation (Aim 3). Finally, I will interrogate the effects of
sex hormone signaling on tanycyte circadian-metabolic function (Aim 4). To pursue these aims, I will use a
combination of cellular and molecular assays (immunolabeling, single-cell RNA sequencing), functional
bioassays (BrdU cell division labeling, stem cell lineage tracing, metabolic phenotyping) and behavioral assays.
Successful completion of this project will offer important advances in understanding both circadian rhythms in
tanycyte metabolic function and behavior. First, understanding molecular mechanisms of the tanycyte rhythms
will further define the role of the clock in gating periphery to brain communication. Second, it will provide new
insights into the regulation of food intake. Third, it will identify novel pathways through which diet and sex
differences influence the circadian transcriptome. Understanding the temporal gating of tanycyte function under
pathophysiologic conditions is important for developing interventions to improve human health.
Plan for Career Development: My training plan leverages a highly complementary co-mentorship arrangement
between Dr. Amita Sehgal and Dr. Stewart Anderson who possess deep expertise in circadian
rhythms/metabolism and stem cell metabolism/neurogenesis respectively. I will receive significant consultative
support from Dr. Ron Anafi of the University of Pennsylvania Center for Subcellular Genomics and Drs. Joseph
Baur and Corey Holman, directors of the Rodent Metabolic Phenotyping Center at Penn. My research and
transition to independence will benefit from this strong mentorship team, state-of-the-art facilities/equipment, and
professional development resources offered through the Penn office of Biomedical Postdoctoral Programs.

Public health relevance
Project Narrative Circadian rhythms are ubiquitous, endogenous timekeepers that optimize many metabolic functions to the advantage of the organism; prolonged disruption of rhythms results in deleterious health consequences. The role of the circadian clock in tissue-specific metabolic functions, such as that of tanycytes (specialized hypothalamic glia), is poorly understood. The goal of this study is to understand the relevance of the circadian clock in tanycytes in acting as a temporal gate for endocrine signaling, adult neurogenesis, and behavior.